Administrative Core

Abstract
Congenital heart disease (CHD) is the most common birth defect. Among various CHDs, defects that result in
altered ventricular morphogenesis have the poorest clinical prognoses. Currently, there is a poor
understanding of the molecular mechanisms and cellular etiology causative of the many forms of ventricular
CHDs. The central theme of this Program Project Grant is to elucidate mechanisms that regulate growth and
morphogenesis of the ventricle during development.
Core A provides central administration of the Program Project Grant activities, which serves to enhance
scientific interactions, resource sharing, collaborative interactions, and compliance requirements for all
participants of this Program Project grant. The ultimate goal of Core A is to enhance Project efficiency and
scientific output.
Relevance:
CHDs resulting in ventricle phenotypes have the poorest clinical outcomes. Thus, gaining an understanding of
the etiology and molecular mechanisms that cause CHDs resulting in altered ventricular morphogenesis has
the potential to benefit thousands of pediatric patients annually.